Strategies for discerning chemotherapy response and resistance in ovarian cancer

Project Summary/Abstract
Ovarian cancer is the fifth leading cause of cancer death among females. Most cases of ovarian cancer are high-
grade serous ovarian cancer (HGSOC), which accounts for most ovarian cancer mortality. In spite of the
increasing knowledge of this tumor type, the use of “old” DNA-damaging chemotherapeutic drugs remains the
first option for ovarian cancer patients. The standard treatment of HGSOC involves de-bulking surgery followed
by platinum-based chemotherapy with the aim to eliminate all the remaining micro-metastases. Unfortunately, a
significant number of HGSOC patients do not respond or only partially respond to these treatments. A patient
who does not respond to platinum chemotherapies has to go through the same treatment and experience the
toxicity without meaningful benefit. Despite the rapid advances in cancer genomics and precision medicine in
the last decade, what remains surprising is that no robust molecular biomarker that can foretell patient response
to platinum agents has been identified in ovarian cancer, pointing to the need for the incorporation of functional
metrics and early-stage molecular changes into the predictive framework. We hypothesize that early-stage
molecular and functional alterations upon drug exposure that underlie how tumor cells orchestrate a response
to the drug treatment are dictating longer-term therapy responses and thus critical to the development of
predictive models. We further hypothesize that the drug susceptibility and bioenergetic dependency of the patient
tumors are important functional readouts for such a prediction. We propose to integrate early-stage temporal
genome, transcriptome, metabolic phenotypes, drug susceptibility, and histology information into machine
learning models to discern a set of metrics most predictive for patient-specific responses to platinum
chemotherapy in HGSOC. This is enabled by a strategic integration of a freshly prepared, precision-cut tumor
slice culture model, an innovative single-cell on-chip metabolic cytometry assay, and a novel in situ spatial
metabolic profiling assay on live tissues. Upon successful completion, this study could deliver a predictive
diagnostic assay for identifying HGSOC patients with a higher risk of resistance to platinum chemotherapy, as
well as patients who may benefit from such treatments, prior to the onset of therapy. These results will provide
innovative molecular and functional information complementary to tumor genetics and other clinical factors for
more informative clinical decision-making and help re-direct platinum-refractory patients to other therapeutic
approaches or clinical trials of novel therapies before the treatment.

Public health relevance
Project Narrative Accurate prediction of responders and non-responders to platinum chemotherapy before the onset of therapy is a crucial unmet clinical need in the management of HGSOC. We propose to develop a predictive framework that integrates early-stage molecular and functional dynamics of patient tumors upon drug treatment with machine- learning models. Successful completion will deliver a complementary method to current clinical guidelines for predictive HGSOC diagnostics.